Heart Failure Therapy by CRISPR-Mediated Upregulation of Mitochondrial Biogenesis

Mitochondrial dysfunction has been implicated as a contributing factor for heart failure. Genes involved in mitochondrial biogenesis and quality control such as the peroxisome proliferator- activated receptor gamma coactivator 1α (PGC-1α) have been severely downregulated in rodent models of heart failure. Transcription of PGC-1α can be promoted when cAMP Response Element Binding Protein (CREB) is phosphorylated at Ser-133 by PKA upon beta-adrenergic signaling. However, recent evidence shows that CREB itself has numerous factors modulating it, including phosphorylation on other sites (e.g Ser-142), availability of dimerization partners (c- Jun, CREB subtypes) and other co-factors (e.g. TORCs) that may be altered in heart failure. Here we will test whether bypassing the complex regulatory steps involved in PGC-1α activation and directly targeting cAMP Response Elements (CRE) known to regulate PGC-1α gene expression can have beneficial effects on expression of PGC-1α. Importantly, we also propose to test whether mitochondrial biogenesis can be increased via CRE-mediated PGC-1α upregulation. I intend to utilize the newly developed CRISPR/Cas9 technology as a transcriptional activator (instead of editing genes, with inactivated Cas9 fused to transcriptional activation domains) to target CRE sequences to promote transcription of PGC-1α. Use and efficacy of these gene modulating tools has not been evaluated in cardiomyocytes. With this project, I will establish if metabolic reprogramming and enhanced mitochondrial biogenesis can be effected with CRISPR-mediated activation of PGC-1α while providing fundamental knowledge of the role of CRE in PGC-1α activation and mitochondrial function. I would have also developed a streamlined and generalizable method for using gene modulating tools for expression and begun to test its efficacy in preventing or reversing heart failure.

Public health relevance
Project Narrative Mitochondrial dysfunction is a precipitating factor for heart failure. A new genome targeting tool called CRISPR-Cas9 shows great promise as a therapeutic by directly targeting a gene for up- regulation. Their mechanism, behavior, efﬁciency, feasibility for improving mitochondrial function in cardiomyocytes have not yet been evaluated and I aim to characterize this.